Multi-level associations between opioid use and overdose: Individual, clinical, and population-based risk factors for fatality

PROJECT SUMMARY: Over the past two decades, high rates of opioid prescribing have led to widespread
opioid use and epidemic levels of adverse opioid-related outcomes. Early interventions focused on reducing
opioid prescribing through the development of practice guidelines and implementation of programs and policies
to increase prescription opioid management and monitoring. While overall opioid prescribing has declined in
recent years and may have contributed to reductions in prescription opioid-involved overdose death rates in
2012 and 2013, the rate has since risen to a new high, comprising 40% of all opioid-related deaths in 2016.
Furthermore, prescribing remains elevated in disadvantaged groups and areas, highlighting a need to better
understand how individual characteristics intersect with health system and population-level factors in the
pathways from opioid use to fatal and non-fatal overdose. Using a multi-level approach, the proposed project
examines trajectories from opioid treatment for chronic non-cancer pain to opioid overdose and fatality,
accounting for: 1) individual sociodemographic and clinical characteristics (e.g. sex, age, race/ethnicity,
comorbidities), 2) opioid treatment patterns (e.g. dosage, duration, formulation), 3) county-level health system
(e.g. facilities, services) and population characteristics (e.g. percent poverty, minority, unemployed, disabled),
and 4) state-level policies (e.g. Medicaid policies, Prescription Drug Monitoring Programs). Opioid treatment
patterns will be assessed using national Medicaid Analytic Extract (MAX) data, adjusting for individual
characteristics. Risk of overdose based on individual characteristics and treatment patterns will be assessed
using MAX data for medically treated non-fatal opioid overdose and National Death Index (NDI) data for fatal
opioid overdose. Overdose outcomes will be further assessed using county-level Area Health Resource File
(AHRF) data and state-level policy measures. Contextualizing individual outcomes within wider health care
systems and social and geographic settings supports NIDA’s strategic plan to increase the public health impact
of research. Additional substantive and methodological training will contribute to the applicant’s long-term goal
to develop an independent academic research career and generate and disseminate robust evidence to inform
effective interventions to reduce opioid-related morbidity and mortality. The training aims include advanced
study and application of: 1) innovative methods to characterize clinical care patterns over time, 2) social and
spatial epidemiology theory and methods to study multilevel influences on health, 3) policy drivers of health
and health care, and 4) professional development for conducting ethical, independent research. The research
and training are supported by an interdisciplinary mentorship team of Columbia University researchers with
expertise in substance use and policy research, clinical and spatial epidemiology, and statistics with additional
support from external collaborators in health services and policy research methods. This project and career
development plan will prepare the applicant to secure R01 funding to extend this line of research.

Public health relevance
PROJECT NARRATIVE: The proposed project will apply novel methods to identify a comprehensive set of individual sociodemographic and clinical characteristics that define longitudinal patterns of prescription opioid use for chronic pain and predict transitions to fatal and non-fatal overdose in vulnerable groups. This project will also examine linkages between prescription opioid treatment trajectories and broader social and structural characteristics to understand how population-level sociodemographic and socioeconomic factors, the distribution of health care resources, and state policies influence risk of opioid overdose and fatality at the individual level. The research will contribute fundamental knowledge about the patterns and risks associated with opioid prescribing practices for pain management and identify areas where programs and policies are needed to improve health care access and quality to ultimately reduce the risk of opioid overdose and death.